CLINICAL ELECTROPHYSIOLOGY OF RETINA/PIGMENT EPITELIUM

Our goal is to develop and evaluate several clinical electrophysiological tests which may enhance our ability to diagnose and manage disease. We are concerned primarily with two areas, tests of retinal pigment epithelial (RPE) function, and tests of dopaminergic retinal pathways that may correlate with disorders such as schizophrenia. The assessment of RPE function is important because the RPE is involved in a wide variety of ocular disorders. No specific diagnostic tests for the RPE currently exist, and we will investigate several potential candidates: 1) the fast oscillation, a light-induced response generated at the basal RPE membrane; 2) a standing potential response, produced without light by making the subject hypoxic and then restoring oxygenation suddenly; 3) changes in the standing potential induced by intravenous injection of a hyperosmolar solution or acetazolamide. All of these responses can be recorded for clinical purposes with the EOG. We will first work with normal subjects to standardize the tests and develop protocols that are suitable for general clinical use. We will then study patients with known retinal and RPE disease to evaluate diagnostic specificity, and, if warranted, extend the evaluation to a larger group of patients undergoing prospective electrophysiologic testing. We will also complete some studies on the c-wave, although our previous work has shown this response encounters difficulties as a clinical procedure. Objective criteria for diagnosing or following schizophrenia are critically needed. Dopaminergic neural processes have been implicated in disorders such as schizophrenia or Parkinson's disease, and also may contribute to the oscillatory potentials of the ERG. We will investigate whether oscillatory potential changes can be associated with schizophrenia or with Parkinson's disease.